Animal Physiology and Phenotyping Core

Core A Project Summary/Abstract Scientists are generating unique disease models by manipulating single
genes and proteins in whole animals, targeted organs and individual cells. Absent at many of the top research
institutions are individuals experienced in performing procedures to ascertain the physiological role of these
genes and proteins in normal function and disease. This is particularly true in studying the kidney because
phenotyping kidney function may require evaluating individual nephron and whole kidney function, and the role
the kidney might play in disrupting systemic homeostasis. The overriding goal of the Yale George M. O'Brien
Kidney Center Animal Physiology and Phenotyping Core is to provide performance and training services to
assist Users phenotype their particular rodent disease model at the systemic, whole kidney and individual
nephron segment levels, as appropriate for the model. This breadth of phenotyping services within one Core
program facilitates renal research by making it possible for a single animal to be used in more than one
phenotyping activity, decreasing the total number of animals need for a thorough phenotyping project. While
many of the services offered by the Core were once considered standard laboratory techniques and assays,
and were the backbone of the renal labs that originally described normal renal physiology and pathology, there
are currently only a small number of institutions with individuals capable of offering this level and breadth of
renal function phenotyping. Yet, increasingly, these techniques and assessment approaches are needed to
understand whole kidney and nephron function following genetic, experimental and/or environmental
manipulations. Thus, the Animal Physiology and Phenotyping Core has three major strengths: 1) the
equipment and infrastructure to assist with renal disease model development and provide phenotyping
services at the systemic, whole kidney and individual nephron segment level, 2) experienced and skilled
personnel capable of generating reliable and reproducible phenotyping data and 3) expertise and experience in
designing phenotyping studies and data interpretation. Core staff perform the more difficult phenotyping
techniques, e.g., renal clearance studies, kidney perfusion fixation, acute and chronic BP measurements and
assaying plasma and urine solute content. For other techniques, e.g., balance, circadian rhythm and activity
studies, the Core staff work with Users to ensure the studies are performed correctly, but Users perform the
majority of the work. In addition, Core staff assist Users with the proper technique for sample collection, e.g.,
blood and spot urine collections, and data analysis and interpretation. Thus, by generating data for Users when
more specialized or difficult techniques are needed and assisting labs when less difficult techniques are
needed, the Animal Physiology and Phenotyping Core can assist the largest number of renal research
programs. Core A offers 17 distinct services. During the previous funding period it provided 23,800 services to
59 investigators, which supported studies in >60 manuscripts and 15 funded grant applications.